Fat-Muscle Cross-Talk in the Injured Rotator Cuff

PROJECT SUMMARY Persistent shoulder pain, stiffness and weakness are common symptoms of chronic rotator cuff (RC) tears that limit function and decrease quality of life for >10% of the population over age 60. Degeneration of RC muscles, particularly the accumulation of fat within and around these muscles, is thought to be linked to persistent shoulder dysfunction, but the nature of this link remains undefined. The long-­term objective of this research is to understand the role of fat-­muscle crosstalk on the processes of muscle degeneration and regeneration. Currently, the accumulation of RC fat is thought to be an irreversible feature of chronic RC tears that contributes to poor surgical and rehabilitative outcomes. We believe, however, that the unique properties of RC fat make it a novel therapeutic target to promote, rather than inhibit, muscle functional recovery. Specifically, RC fat has a beige phenotype that may be stimulated to take on some properties of brown fat, such as the local secretion of anabolic factors. Accordingly, for this application, our primary objective is to elucidate the cellular targets and downstream effects of phenotype-­specific fat-­muscle cross-­talk in the injured rotator cuff. Our central hypothesis is that anabolic signaling from brown fat mitigates muscle atrophy and promotes muscle hypertrophy. To address our hypothesis, our approach will be to adapt models of RC injury and repair to include transplant of known fat phenotypes (brown, beige and white) and quantify the downstream effects on muscle size, strength and intracellular signaling. Specifically, Aim #1 will identify the effects of RC fat-­muscle cross-­talk on atrophic changes in an experimental model of RC tear and Aim #2 will determine the potential for brown fat to promote muscle hypertrophy following repair of the tear. Altogether, these studies will broaden our understanding of the contribution of RC fat accumulation to muscle pathology and the nature of fat-­muscle crosstalk in general. Ultimately, we expect this will have a significant impact on the development of treatment strategies designed to target fat accumulation, not only in the RC but also in other conditions such as aging and type 2 diabetes where fat accumulation is thought to impact muscle function.

Public health relevance
PROJECT NARRATIVE Accumulation of fat in the muscles of the rotator cuff is a hallmark of chronic tears and is thought to contribute to persistent shoulder weakness and functional limitations. These experiments aim to define the nature of the interaction between fat and muscle in the rotator cuff with a specific focus on the role of fat phenotype. Knowledge gathered from this work will inform the development of therapies targeting fat in the rotator cuff to improve muscle function and quality of life for the nearly 10 million Americans with chronic rotator cuff tears.